2019 Organellar Channels and Transporters Gordon Research Conference and Gordon Research Seminar

Abstract This project aims to support attendance of young faculty, under-represented minority scientists, graduate students and post-docs at the 2019 Gordon Research Conference (GRC) and associated student/postdoc-run Gordon Research Seminar (GRS) on “Organellar Channels and Transporters.” These GRS and GRC will be held in West Dover, Vermont, on August 3-4 and August 4-9, 2019, respectively. These meetings will bring together scientists from many disciplines working on membrane transport proteins from a wide variety of intracellular organelles in animal, plant, and fungal systems. They aim to capture the most recent discoveries in the field and the emerging trends of integration among different organelles and processes, as well as their relevance for the understanding and treatment of common and rare human diseases associated with the dysfunction of organellar channels and transporters. The meeting will consist of platform sessions, short talks, poster sessions, round tables, communal dining, and plenty social times and conversations that will provide ample opportunity for sharing latest research results as well as technical and conceptual advances, for exploring collaborative possibilities, and for identifying new ways to treat human diseases. We request funds from NCATS (as Primary Institute) and NIAMS (Secondary Assignment) to support junior invited speakers (assistant and associate professors) who have achieved breakthrough discoveries at their early career stage; to facilitate attendance of graduate students, postdoctoral fellows, and junior faculty, including but not limited to women and/or other minorities at the GRS and GRC; and to foster productive scientific and career consulting discussions between senior and young scientists.

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference on Organellar Channels and Transporters, held for the 3rd time in 2019, is dedicated to ion channels and primary or secondary transporters from intracellular organelles in animals, plants, and yeasts. It aims to bring together students, postdocs and early career to senior scientists working in fields from plant biology to human diseases to share new, unpublished work and identify new concepts and challenges in this rapidly expanding field.